Metabolic & Molecular Physiology

ABSTRACT MMPC
NIH-initiated efforts to centralize expertise, instrumentation, and facilities to promote comprehensive
evaluation of genetically engineered mice, tissues and cells has improved our understanding of functional
genomics and disease pathobiology. The Metabolic and Molecular Physiology Core (MMPC) provides
investigators from UCSD, UCLA, and their affiliated institutions with a series of state-of-the-art and cost
effective molecular and physiological assays not readily available from national phenotyping centers. The
MMPC is divided into four sub-cores: A) Hormone sensitivity, body composition, and energy homeostasis,
B) Oxidative metabolism and exercise capacity, C) Mitochondrial biology, metabolism, and imaging, and
D) Inflammatory signaling and diabetes complications, and each sub-core offers extensive training and
consultation on a variety of topics from experimental design to data interpretation and integration.
Specifically, the MMPC provides services to assess movement, feeding behavior, indirect calorimetry,
body composition, glucose/insulin tolerance, insulin action (ex vivo, in situ, and in vivo), substrate
metabolism and oxidative capacity, mitochondrial function and morphology, circulating hormones /
adipokines / cytokines, and diabetes complications. The MMPC maintains an unparalleled tissue biobank
as well as a comprehensive database of phenotypic outcomes for a wide variety of genetically engineered
mice and standard protocols for a vast number of phenotyping techniques. MMPC leadership includes
top investigators from the fields of integrative metabolism, nuclear receptor biology, mitochondrial
function and architecture, and inflammation including Andrea Hevener, Orian Shirihai, and Zhenqi Zhou.
Strengths of the MMPC include a well-rounded and complementary expertise of its leadership, an
exceptional track record of research productivity, and high impact scientific publications. The
collaborative spirit of the MMPC team fosters a collegial environment and supports service well-
coordinated with other DRC cores and institutional resources. The central goal of the MMPC is to advance
the scientific capabilities of the DRC membership in leading-edge metabolic analyses and improve overall
research quality with enhanced translation of research ideas from cells, tissues, and mice to human.